The behavioral microstructure of a memory-guided food-caching behavior and its relationship to hippocampal replay

Project Summary
The hippocampus is a critical site for rapid memory formation and retrieval, with extensively documented
functions representing spatial and navigational variables, yet less is known of the means by which it guides
behavior. Bursts of hippocampal activity identified in many species as sharp-wave ripple (SWR) events are
promising neural mechanisms to link hippocampal activity and behavioral function, since during SWRs
hippocampus can represent positions the animal previously experienced, or will traverse in the near future.
This proposal considers the food-caching behaviors of chickadees, who use a hippocampal-dependent, one-
shot memory to guide cache retrieval. This behavior is exceptionally promising to link hippocampal activity to
individual experiences, which has been a barrier to determining the nature of representations during SWR and
their function in previous studies. These studies will develop a comprehensive account of how chickadee
behavior is affected by cache site memory, determine whether SWRs are related to memory-specific
components of caching behavior, and determine whether SWRs represent individual cache sites to assist later
retrieval.
I hypothesize that memory-guided behavior is distinguishable from random foraging. I will use video tracking to
measure the behavioral microstructure of chickadee caching behavior, including postural and gaze time series,
and develop quantitative models of behavioral motifs and their temporal structure. Using these tools to
compare memory-guided and random foraging behaviors, I will develop decoders that indicate precisely how
and when behavior appears memory-guided.
I hypothesize that SWRs occur more often, and are more predictive of behavior, when behavior is memory-
guided. I will use electrophysiology in freely moving chickadees during caching to relate SWRs to the
microstructural analysis of behavior and decoding of behavioral strategy.
I hypothesize that SWRs reactivate representations of previous, individual caching events, and that this
reactivation improves subsequent retrieval for that individual site. Using electrophysiological recordings in
caching birds, I will relate reactivations to the accuracy of retrieval behavior. Using online SWR detection and
suppression, I will further determine if SWRs causally affect later retrieval behavior.

Public health relevance
Project Narrative Food caching birds are a unique model system for dissecting the fundamental principles of hippocampal function. Thorough characterization and computational modeling of this behavior, and the specific contribution of hippocampal memory, will allow insight into the neural mechanisms by which hippocampal representations guide behavior. We expect the principles resulting from this study to illuminate dysfunctions of memory present in many neurological disorders.